TESTOSTERONE REPLACEMENT ON LEAN BODY MASS IN MEN WITH HIV RELATED HYPOGONADISM

The primary objective of this study is to evaluate the effectiveness of two regimens of testosterone in increasing lean body mass as measured by dual energy x-ray absorptiometry (DEXA) and bioelectrical impedance analysis (BIA) in HIV-infected hypogonadal men.